Automated Presurgical Language Mapping via Deep Learning for Multimodal Brain Connectivity

Project Summary/Abstract
Approximately 100,000 people in the United States are diagnosed with a primary brain tumor each year. Neu-
rosurgery remains the ﬁrst and most common therapeutic option for these patients with outcomes linked to the
extent of tumor resection. However, larger resections also increase the risk for postoperative deﬁcits, particularly
in the motor and language areas of the eloquent cortex. Task fMRI (t-fMRI) has emerged as a powerful nonin-
vasive tool for preoperative mapping, but these acquisitions are lengthy and cognitively demanding for patients.
Moreover, t-fMRI is unreliable if the patient cannot perform the tasks while in the scanner. Our long-term goal is
to develop an automated platform for reliable eloquent cortex mapping across a broad patient cohort that comple-
ments the existing clinical workﬂow. The overall objective of this proposal is to design and validate new machine
learning algorithms that leverage the complementary strengths of resting-state fMRI (rs-fMRI) and diffusion MRI
(d-MRI), which are both passive modalities and easy to acquire. Our central hypothesis is that the combined
structural-functional connectivity information in these modalities will enable us to localize language functionality
in patients with brain tumors. Our innovative strategy uses recent advancements in deep learning to capture com-
plex interactions in the rs-fMRI and d-MRI data that collectively deﬁne the language areas. We will evaluate our
hypothesis via two speciﬁc aims. In Aim 1 we will develop a graph neural network (GNN) that employs specialized
convolutional ﬁlters to capture topological properties of the connectivity data across multiple scales. Our GNN
will be trained in a supervised fashion and evaluated against t-fMRI activations and intraoperative electrocortical
stimulation. In Aim 2 we will conduct an exploratory analysis to retrospectively link our GNN predictions to post-
operative changes in language functionality. Namely, we hypothesize that patients for whom the surgical path
intersects our GNN predictions will experience greater deﬁcits across ﬁne-grained language subdomains. We will
also assess the prognostic value of our GNN predictions, as compared to other clinical factors. We anticipate the
proposed research will have a transformative impact on surgical planning by helping neurosurgeons to plan more
targeted and safer surgeries, thus improving patient outcomes and overall quality of care.

Public health relevance
Project Narrative The proposed research addresses a critical and unmet public health need in managing primary brain tumors by improving the accuracy of eloquent cortex mapping during preoperative planning. The algorithms developed through these efforts will help to streamline the surgical procedures and mitigate the risk for postoperative deﬁcits, towards the ultimate goal of improving both quality of care and long-term clinical outcomes.